PRECEDE II Presurgical Cognitive Evaluation Via Digital Clockface Drawing Focusing on Disparities

Project Summary
Preoperative cognitive impairment is a significant predictor of postoperative complications. However, despite
recommendations for preoperative cognitive screening in older adults, current tools, like the clock drawing test,
face challenges in accurately assessing patients with low education and limited reading. The overall objective
of this application is to examine how education impacts clock drawing production, how it modifies its predictive
value on the postoperative outcome, and how to evaluate its screening accuracy compared to alternative tools
for detecting preoperative cognitive impairment in less-educated patients. Building on the productivity and
infrastructure of the original R01, this renewal will develop and validate innovative approaches tailored to
sociodemographically diverse patient populations. The rationale is that improving cognitive screening tools for
older adults with varying educational backgrounds will lead to better detection of preoperative cognitive
impairment and enhanced prediction of postoperative complications. The overall objective will be achieved by
pursuing three specific aims. (1) Preoperative Features: Develop an explainable AI-augmented digital Clock
Drawing (dCDT) tool that considers educational disparities in cognitive features among older adults undergoing
surgery, hypothesizing that certain clock drawing features will be absent in individuals with lower education
levels. (2) Postoperative Outcome: Create a multimodal federated learning model to enhance predictive
accuracy for postoperative outcomes, integrating preoperative cognitive and intraoperative data with
sociodemographic factors. (3) Prospective Validation: Evaluate the accuracy of dCDT against two alternative
digital metrics (Paragraph Recall and Symbol Cancellation) for identifying cognitive impairment in low-
education older adults, with a hypothesis that dCDT metrics may underperform compared to these novel
metrics. The approach is innovative because it represents the first attempt at (1) the focus on cognitive
assessment accuracy in the lower education older adult patient population, (2) the comprehensive integration
of explainable AI in the dCDT tool, and (3) the use of federated learning for cognitive predictive modeling. The
proposed research is significant as it addresses critical gaps in perioperative cognitive assessment, enabling
fair and accurate evaluation of older adults with lower education. The expected outcomes include improved
perioperative cognitive screening tools, better prediction of postoperative complications, and enhanced care for
older adults at risk for cognitive impairment.

Public health relevance
PROJECT NARRATIVE This project will leverage a modernized digital Clock Drawing Test (dCDT) to assess how education influences cognitive screening in adults aged ≥ 65 undergoing surgery. It will evaluate how dCDT features combined with intraoperative data predict postoperative outcomes and compare dCDT accuracy to novel digital metrics for detecting cognitive impairment in less-educated adults and adults with limited reading. Findings will inform strategies to enhance perioperative cognitive health and reduce health disparities.